Intracranial multimodal physiological monitoring in acute brain injury

PROJECT SUMMARY
Present day multimodal monitoring for traumatic brain injury (TBI) is limited in its implementation as it
necessitates multiple invasive probes to measure intracranial pressure (ICP), intracranial EEG (icEEG),
intracranial temperature (icT), and brain tissue oxygen (PBTO2), the majority of which require their own
instrumentation and monitors. While there is increasing evidence to support multimodal monitoring in TBI and
other acute brain injuries, the present cumbersome systems make it nearly impossible to use outside of major
Level 1 trauma centers. The challenges include the need for expertise with both probe placement and data
interpretation as well as the integration of multiple electronic units from different vendors with diverse software
systems, each requiring training, IT and biomedical engineering support. Coupled with this is an increased risk
of bleeding and infection from the multiple entry points into brain parenchyma. Our objective is to develop a
single source brain monitoring solution for the management of severe TBI. We will integrate the modalities
indicated for severe TBI (ICP, icEEG, icT, PBTO2) in a brain implantable device called the NeuroProbe with a
target diameter which is equivalent to, or smaller than, individual current probes. We will develop a single
interface device called the NeuroLink to acquire the multi-modal intracranial data from the NeuroProbe as well
as scalp EEG and patient physiological data including systemic blood pressure (SBP), heart rate (HR), mean
arterial pressure (MAP) and blood oxygen (SpO2) and transmit these sensor signals to monitors as a time-
locked single digital data stream. We will develop a display unit called the NeuroMonitor to analyze and display
the acquired multimodal data in a synchronized real-time manner. We call the composite solution created by
the NeuroProbe, NeuroLink, and NeuroMonitor devices the NeuroProbe Solution. The technological
development of the NeuroProbe Solution dramatically expands the capabilities of the existing icEEG depth
electrodes developed at Yale University and multimodal probes currently on the market. The key innovations of
the NeuroProbe Solution are:
1. Integration of multiple physiologic sensors on a single intracranial probe (NeuroProbe).
2. Simplification of NeuroProbe to allow placement at bedside in a civilian or military facility.
3. Development of a multimodal interface device (NeuroLink) to store and relay time-locked digital data
acquired from the NeuroProbe and extracranial sensors to the NeuroMonitor and other clinical monitors.
4. Development of an iPad sized monitor (NeuroMonitor) to analyze and display multimodal data.
5. Time-locked multi-stream data transfer which allows for real-time and post-hoc data review and analysis.
This innovative solution allows acquisition and integration of data from multiple physiological parameters
through a standard small tablet creating a simple single end-to-end solution from sensors to multimodal data
analysis and display in an otherwise fragmented and complex domain.

Public health relevance
NARRATIVE The present approach for brain injury monitoring employs multiple invasive brain probes with each probe providing a different measurement which must be individually visualized, analyzed and integrated by the physician. We will develop a brain monitoring solution (the “NeuroProbe Solution”) based on a single probe that will combine the function of multiple individual brain probes. The NeuroProbe Solution has many advantages over current solutions including improved safety, better total patient physiology data integration and a lower cost, and is, thus, expected to lead to improved monitoring and personalized care of patients with brain injury.